Imaging Core

The Imaging Core will provide support for the acquisition, analysis and interpretation of magnetic resonance imaging data that is being collected in the Center Projects. More specifically, the core will be responsible for developing and maintaining pulse sequences and protocols that will be used in the Projects, and will also be responsible for ensuring high and consistent image quality. Imaging protocols for human infants and adolescents, and very young nonhuman primates will be employed for structural, microstructural (diffusion tensor imaging), functional (both resting/sleeping and task-based) mapping of the brain. The core will also be responsible for developing and maintaining image analysis pipelines used in the projects. These include methods for analyzing structural morphometry (including amygdala and prefrontal volumes), diffusion tensor imaging measures of amygdala, limbic and prefrontal white matter pathways, task-based functional MRI measures and resting-state functional connectivity measures. Selective strategies for analysis in very young monkeys and human infants will be developed to facilitate measurements in the young brain with immature myelination. Finally, the core will help to evaluate and implement new image acquisition techniques and image analysis strategies that the Center investigators deem to provide novel useful and/or more accurate measurements.

Public health relevance
RELEVANCE (See instructions): This Center will relate measurements of brain macrostructure, microstructure and function to measures of anxious temperament in both prospective (infant/toddler) and retrospective (adolescent) designs for both human and nonhuman primates. Accurate measures of brain structure and function are essential for improving the understanding the role of neurobiology on the development of anxiety and related disorders.